Bioinspired Point of Care Testing for HIV/HBV Co-infection

Project Summary
Hepatitis B virus (HBV) poses a persistent global health threat, affecting millions annually and leading to
significant mortality. Co-infection with human immunodeficiency virus (HIV) compounds the health challenges,
necessitating accurate diagnostics for effective management. Our project aims to develop a cost-effective and
user-friendly point-of-care (POC) diagnostic tool, employing a novel CamoChip technology for highly sensitive
and multiplex biomarker testing. This innovation, integrated with an AI-based algorithm, offers the potential to
empower healthcare providers, enabling tailored treatment and the prevention of new infections.
Our approach centers on a microchip utilizing color-encoded beads coated with antibodies for the capture
of vital biomarkers, including HIV-1 RNA, HBV DNA, HBsAg, HBeAg, and ALT. The microchip's camouflaging
mechanism ensures biomarker identification, making it an ideal candidate for widespread use in diverse
healthcare settings.
Our project is structured around three specific aims. Specific Aim 1 focuses on designing and coating
color-encoded beads for biomarker capture. Specific Aim 2 seeks to enhance the camouflaging reaction on the
microchip. Specific Aim 3 involves engineering a cost-effective and portable microfluidic device for mass
production, ensuring ease of use and compatibility with diverse testing scenarios and environments.
The proposed CamoChip approach integrates serological and molecular tests for HIV and HBV co-
infection into a single platform, eliminating the need for separate tests and visits. It reduces delays in treatment
initiation and monitoring, enhancing patient care. CamoChip's user-friendly design and simplified interpretation,
utilizing color-encoding and AI, enable rapid diagnosis and monitoring within minutes, allowing healthcare
providers to make timely treatment decisions during the same visit. Designed for POC testing, CamoChip is
accessible in diverse healthcare settings, including remote or resource-limited areas. Its portability and ease of
use ensure optimal outcomes for patients with HIV and HBV co-infection. Adhering closely to CDC and WHO
guidelines, CamoChip empowers healthcare providers to deliver high-quality care with confidence and efficiency,
even in challenging clinical settings.

Public health relevance
Project Narrative Accurate and comprehensive testing for HBV and HIV-1 is imperative within the context of cure and eradication strategies for these diseases. These viruses exhibit a significant degree of interconnection, sharing common risk factors and modes of transmission, resulting in a substantial prevalence of HIV-HBV coinfection. To address this challenge, we propose harnessing the potential of emerging camouflage microfluidics technology, coupled with advancements in nanotechnology and AI-empowered image analysis. Our objective is to pioneer the development of the first integrated point-of-care (POC) test for HIV/HBV co-infection, representing a groundbreaking advancement in diagnostic tools. This platform holds immense promise to enhance health outcomes and save lives not only in the context of HBV and HIV-1 co-infection but also in addressing various other infectious diseases.